VALIDITY OF THE PHYSICAL ACTIVITY INTERVIEW AND CALTRAC MOTION SENSOR

The purpose of this study is to assess the validity of the Physical Activity Interviews (PAI) and Caltrac assessments of moderate and vigorous physical activity of 3rd- and 5th-grade children, compared with monitored heart rates.